Dynamics of calcium signals control neurotransmitter release in retinal ribbon synapses.

Project Abstract
Dementias, including those associated with Alzheimer's disease (AD), are major neurodegenerative disorders
that cause visual problems due to pathologic changes in the retina and optic nerve and higher cortical
impairment. In AD these include changes in contrast sensitivity, visual acuities, and color vision. Despite the
growing idea that the retina can be used in early diagnosis of AD, little is known about the underlying
mechanism associated with AD histopathology markers and visual impairment. These mechanisms must be
deciphered for the development of effective therapeutics for AD. Sensory synapses in the retina rely on the
proper function of the synaptic ribbon, which is a specialized organelle anchored to the presynaptic active
zone. Synaptic dysfunction (synaptopathy) is a critical common biological mechanism that links protein
pathologies to AD symptoms. The long-term goal of our parent research program is to reveal the regulation of
Ca2+ signaling in retinal ribbon synapses during development, normal adulthood, and disease states that affect
the retina. While in the parent research program focuses on local Ca2+signaling and its interplay with the
vesicle replenishment required for neurotransmitter release, the supplementary research program will apply
this knowledge to AD. Our approach to both projects uses a confluence of state-of-the-art techniques, including
fluorescence imaging, voltage-clamp electrophysiology, computational modeling, electron microscopy of
individual physiologically identified cells, and pharmacological tools. We will use a novel and robust model for
AD in adult zebrafish treated with okadaic acid (OKA) that exhibits the holistic representation of important AD
hallmarks and replicates the memory deficiencies of AD. Our central hypothesis is that AD histopathology
hallmarks that develop in the retina of OKA-treated zebrafish result in the onset and progression of dysfunction
of the bipolar retinal ribbon synapse by altering synaptic vesicle mobility, mitochondrial function, and calcium
dysregulation. Our hypothesis is supported by recent studies in which OKA treatment of zebrafish resulted in
the formation of major histopathological hallmarks of AD, including amyloid beta (Aβ) protein fragments,
neurofibrillary tangles (NFTs), hyperphosphorylated tau protein, and accumulation of senile plaques, leading to
neurodegeneration, cognitive impairments, oxidative stress, neuroinflammation, glial cell activation, glutamate
excitotoxicity, and mitochondrial dysfunction. In objective 1, we will determine the synaptic vesicle dynamics in
retinal bipolar cells isolated from OKA-treated zebrafish, while in objective 2, we will reveal the synaptic
mitochondrial dysfunction and calcium signaling at ribbon synapses in OKA-treated zebrafish. The results of
this research program will allow us to determine whether defects in synaptic vesicle mobility, synaptic
mitochondrial dynamics, and local Ca2+ homeostasis are a prelude to future development of AD. Data
generated from this proposal will extends beyond our specific investigation of bipolar cells to define the role of
synapse loss and dysfunction in AD.

Public health relevance
Project narrative (3 sentences) The proposed research is relevant to public health because synaptic dysfunction is an early pathological event in Alzheimer's disease. Identifying the mechanisms underlying early synaptic dysfunction resulting in visual impairment is critical for developing the next-generation therapeutic strategies to prevent disease progression in the retina and brain, which are beyond the scope of our current R01 grant but are critical for allowing us to pursue these investigations in a future R01 proposal. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disability.